Maintenance and Improvement of NINDS Infrastructure

NATIONAL INSTITUTES OF HEALTH NINDS Facilities Planning / Equipment Bldg 35, GF352-4 The following laboratories and research support areas underwent renovations during FY 2021: 1. Perform a re-design for the Scientific Director Suite. Location NIH Bethesda Campus, Bldg 35A. 2. Perform a renovation for the Veterinary Office space in Bldg 35A. Location: NIH Bethesda Campus, Bldg 35A. 3. Perform renovations for NINDS/NIMH main corridor. Location: NIH Bethesda Campus. Bldg35A. 4. Perform renovation for the Protein/Peptide Sequencing Facility that supports multiple ICs. Location: NIH Bethesda Camus, Bldg 35. 5. Perform additional back-up cooling system for NINDS Server Room. Location Bethesda Campus, Bldg 35. 6. Perform renovation for NINDS EM CRYO Laboratory. Location NIH Bethesda Campus, Bldg 35A. 7. Perform renovation for CRYO-Electron Microscope/Light Imaging? STEM Facility. Location: NIH Bethesda Campus, Bldg 37. 8. Perform renovation to replace the Porter phase1 RO System. Location: NIH Bethesda Campus, Bldg 35. 9. Perform renovation for the Dr. Rebecca Gottesman, Chief Stroke Branch Director. Location: NIH Bethesda Campus, Bldg 10. 10. Perform renovation for the Deputy Stroke Branch Director. Location: NIH Bethesda Campus, Bldg 10. 11. Perform a renovation for PET Scanner Radiation Unit. Location: NIH Bethesda Campus, Bldg 49 12. Perform a renovation for Dr. Erika Sasaki, Laboratory of Applied Developmental Biology, Marmoset Research Department, Central Institute for Experimental Animals. Location: NIH Bethesda Campus, Bldg 49. 13. Perform a design and renovation to convert BLS 2 space inro full BSL 3 for Dr. Avindra Nath. Location NIH Bethesda Campus, Bldg 10. 14. Perform a renovation to install 12 AutoClave Machine in the Porter Building. Location NIH Bethesda Campus, Bldg 35. 15. Perform a renovation for Dr. Prashant Chittiboina, Assistant Clinical Investigator, Neurosurgery Unit for Pituitary and Inheritable Diseases. Location: NIH Bethesda Campus, Bldg 10. 16. Perform a renovation for Dr. Leo Cohen, Senior Investigator, Human Cortical Physiology and Neurorehabilitation Section. Location: NIH Bethesda Campus, Bldg 10. 17. Perform a renovation to replace a Rack Washer in the animal washing facility. Location: NIH Bethesda Campus, Bldg 35. 18. Perform a renovation for Dr. Meng Meng Fu, Statdman Investigator, Glial Cell Biology Unit. Location: NIH Bethesda Campus, Bldg 35A. 19. Perform a renovation for Dr. Sonja Scholz, Lasker Clinical Research Scholar, Neurodegenerative Diseases Research Unit, Neurogenetics Branch. Location: NIH Bethesda Campus, Bldg 35. 20. Perform modification to the existing Getinge Steam Sterilizer in the animal facility. Location: NIH Bethesda Campus, Bldg 35. 21. Perform a modification to NINDS Surgical Neurology Branch Conference Room Audio Visual. Location: NIH Bethesda Campus, Bldg 10. 22. Perform a renovation for Dr. Mark Wagner, Tenure-Track Stadtman Investigator. Location: NIH Bethesda Campus, Bldg 49. 23. Renovation and relocation for the Multi-IC Instrumentation Shop. Location: NIH Bethesda Campus, Bldg 13. 24. Perform renovation for Dr. Larry Lotour, Stroke Branch, Stroke Diagnostics and Therapeutics Section (SDTS). Location: NIH Bethesda Campus, Bldg 10. 25. Perform a renovation on Siemens 7T MRI Scanner for MRI Research Facility. Location: Bethesda Campus. Bldg 10. 26. Complete a renovation for Dr. Meng Meng Fu, Statdman Investigator, Glial Cell Biology Unit. Location: NIH Bethesda Campus, Bldg 35A. 27. Complete a modification and Installation for the Animal Facility Conference Room Audio Visual System. Location: NIH Bethesda Campus, Bldg 35. 28. Complete a renovation for the Viral Vector Core Facility. Location: NIH Bethesda Campus, Bldg 35. 29. Complete a renovation for Dr. Yi Gu, Investigator, Spatial Navigation and Memory Unit. Location: NIH Bethesda Campus, Bldg 35. 30. Complete a renovation for Dr. Leo Cohen, Senior Investigator, Human Cortical Physiology and Neurorehabilitation Section. Location: NIH Bethesda Campus, Bldg 10. 31. Complete a renovation for Dr. Daiel Reich, Senior Investigator,Translational Neuroradiology Section. Location: NIH Bethesda Campus, Bldg 10. 32. Complete a renovation for Dr. Kareem Zaghloul, Senior Investigator, Functional and Restorative Neurosurgery Section. Location: NIH Bethesda Campus, Bldg 10. 33. Complete a renovation for Dr. John Ngai, BRAIN Initiative. Location: Bethesda Campus, Bldg 35. 34. Complete a redesign of the Laboratory Sink Drain System in the Animal Facility. Location: NIH Bethesda Campus, Bldg 35. 35. Complete a renovation work on 11.7T Magnet for Dr. Alan Koretsky. Chief of the Laboratory of Functional and Molecular Imaging. Location: NIH Bethesda Campus, Bldg 10. 36. Complete adding humidifier to the animal vivarium. Location: NIH Bethesda Campus, Bldg 49. 37. Completed replacing the trifecta unit that converts the liquid nitrogen to gas, located in the Porter Neuroscience Reserarch Center that supports multiple ICs. Location: NIH Bethesda Campus, Bldg 35. The following pieces of major shared equipment were purchased to support a large number of PIs: 1. Two new BioSafty Cabinets for both Dr. Ngai (Brain Research through Advancing Innovative Neurotechnologies Initiative) and Dr. Sasaki's lab 2. New Brunswick Innova 42 for Viral Production Core Facility 3. Two (2) Panasonic MC0170AICUVLG-PA C02 Incubator and Sartorius Secura 225D-1S for Viral Production Core Facility. 4. New Brunswick S41i INC Shaker for Dr. Miguel Holmgren (Molecular Neurophysiology Unit) 5. Two (2) new 4-foot BioSafety Cabinets for the NINDS Glial Cell Biology unit. 6. Two (2) new 4-foot 1300 Series Biosafety Cabinets for the NINDS Inherited Neurodegenerative Diseases Unit 7. Two (2) Heracell VIOS 160i CO2 Incubator with Copper for Dr. Meng Meng Fu ( NINDS Glial Cell Biology unit)